Discriminating between causes of age-related variegated gene expression

Project Summary: Cells in the same tissue can express the exact same gene at different levels, and this cell-to-cell variation tends to increase with age. Cells in tissues need to coordinate gene expression to maintain homeostasis. Thus, dysregulated variation may be related to, or causative of, the loss of physiological capacities with age. However, the causes and consequences of this increased gene expression variation are not known. In this project I propose to use C. elegans and human tissue culture as model systems to study age-related variation in gene expression between homologous cells in controlled environments. In our prior study, we found strong, cell-specific expression patterns for many reporter genes in young C. elegans animals; that is, for many genes in young animals, the ratio of gene A to gene B expression was fixed in cell type X, and different than in cell type Y. We found that this fixed expression pattern deteriorates with age; in a given cell type genes become expressed at variable stoichiometry in individual animals. Similarly, in mammals, cell-to-cell variation in gene expression observed during aging or senescence is also uncorrelated. Thus, I propose that growing dissimilarity between homologous cells with age may be a conserved phenomenon of aging. I refer to increase of uncorrelated gene expression variation with age as age-related variegated gene expression (VGE). In the proposed project, I will harness both the power of C. elegans and human cell culture to investigate how homologous cells become more dissimilar with age. In the K99 phase of the project I will learn techniques for quantitative microscopy, single cell RNAseq and aging-focused human cell culture methods. Throughout the K99 and R00, I will be investigating potential causes that contribute to age-related VGE. K99-Aim1: I will determine if changes of allele access with age contribute into VGE in C. elegans by analyzing expression from of identical promoters integrated at the identical loci on sister chromosomes. K99-Aim2: I will learn and use single-cell RNA-seq to determine if prevalence of allele bias/monoallelism rises in human fibroblasts with age. R00-Aim3: I will determine what genes and pathways become highly variably expressed with age. I will examine if variable expression of these genes is stochastic or adaptive by determining if expression levels of reporters of these genes predict stress resistance, health or lifespan. These experiments will address the hypothesis that adaptive physiological responses of individual cells to age-related stress contribute to VGE. R00-Aim 4: Using human cell culture, I will determine if cell-to-cell communications propagate VGE among cells with youthful expression patterns ? that is, cells without VGE.

Public health relevance
Project Narrative: Cells in the same tissue can express the exact same gene at different levels, and these deviant differences increase with age. Increased cell-to-cell variation in gene expression is a conserved age-related phenomenon with unknown causes. In this project I will determine what causes gene expression variation to increase with age using C. elegans and human tissue cultures.